A mixed methods approach to address multi-level barriers to care for migratory men living with HIV in South Africa

PROJECT SUMMARY
The spread of HIV in sub‐Saharan Africa has historically followed population movement within and across
country borders. Nowhere is this more evident than in urban centers in South Africa, where the complex
interaction between the world’s largest HIV epidemic and a legacy of forced displacement under Apartheid
has resulted in a significant population of “internal migrants” (those who move within country) who bear
sustained risks across the entire HIV care continuum. The majority are men who migrate to urban centers
seeking employment. Not only do migrant men face intrinsic challenges associated with mobility, but they
also contend with changing internal and societal constructions of masculinity influencing engagement in
care. Given that men with HIV have a two-fold higher mortality rate than women, there is an urgent need to
identify interventions that can effectively link and retain migrant men living with HIV to care.
The current proposal leverages an established partnership between Harvard Medical School and The
Health Economics and Epidemiology Research Office (HE2RO) with the goal of addressing the unique
barriers experienced by internal male men living with HIV in South Africa. We will use a sequential mixed-
methods design to address the following specific aims: (1) To explore, through semi-structured in-depth
interviews, multi-level barriers to engagement and retention in HIV care among internal male migrants living
with HIV who are not accessing care (n=30); (2) To elicit preferred HIV treatment and care attributes and
service delivery features and explore characteristics driving their selection of preferred scenarios using a
Discrete Choice Experiment (n=200); and (3) To co-design an intervention package with our participants
and key stakeholders to promote linkage and sustained engagement in HIV care using Design Thinking.
This proposal is responsive to PA-19-050, focused on “Engaging Men in HIV Testing, Prevention, and
Care,” the new NIH focus on Human Mobility and HIV, and the South African National Strategic Plan for
HIV and AIDS, STIs and TB. This R21 has the potential for a significant impact by generating evidence to
support a multi-level intervention package to improve uptake and retention in HIV care that is responsive to
the unique needs of South African migrant men in a high HIV prevalence urban setting. This multi-
disciplinary team has the cross-disciplinary expertise and proven track-record of engaging hard-to-reach
populations in the communities needed to execute this study.

Public health relevance
PROJECT NARRATIVE Internal male migrants (those who migrate within South Africa) living with HIV face multiple intersectional barriers to care, that result in worse outcomes throughout the care cascade. This project aims to identify key barriers to South African migratory men’s HIV care engagement and their preferences for intervention features, and to co-design an intervention package that is contextually appropriate to promote their engagement in care. We anticipate this project will provide robust preliminary data to inform a future R01 trial to test interventions to improve engagement in care for migratory men that, if successful, can be adapted to other low-resource settings to improve HIV care more broadly in this high-risk population.